MUSCLE METABOLISM &SYMPATHETIC NERVE ACTIVITY

13C isotopomer and 1H NMR analyses of tissue extracts were used to determine the contribution of 13C-enriched octanoate to the acetyl-CoA pool in the rat hindlimb gastrocnemius muscle under isotopic nonsteady-state conditions following an intravenous infusion of 150 and 200 mg (0.88 and 1.17 mmoles) quantities of sodium [2,4,6,8-13C4]octanoate with 350 mg (3.11 mmoles) of unlabeled sodium lactate. From 13C isotopomer analysis, octanoate supplied the bulk of acetyl-CoA to the citric acid cycle (79 1 12% and 57 1 6%), indicating that this substrate was utilized preferentially over endogenous fatty acids and exogenous lactate at both dosage levels. This demonstrated the potential of 13C-enriched octanoate as a probe of skeletal muscle b-oxidation. The glutamate C4 fractional enrichment as measured by 1H NMR was not significantly different from that obtained by 13C-isotopomer analysis in the two sets of experiments (68 1 4% and 58 1 12%). These findings indicate that the direct 1H fractional enrichment measurements of glutamate C4 enrichment in skeletal muscle are consistent with the 13C isotopomer analysis, demonstrating that the sensitivity of 1H NMR spectroscopy can be exploited for measurements of acetyl-CoA enrichment in samples that are too small or dilute for 13C analysis.